ABCD-USA Consortium: Coordinating Center

PROJECT SUMMARY
Health disparities among vulnerable populations in the United States is a serious public health concern. While
health disparities was not in the original scope of the aims of ABCD, there is both a need and an important
opportunity to develop health disparities research focused on adolescents in this national multi-institute funded
consortium.
This health disparities supplement is designed to enact a comprehensive plan to develop a strategy to increase
health disparities research within ABCD. The supplement will provide support for four key components of such
a plan:
1. New leadership within the Coordinating Core of ABCD with health disparities expertise and administrative
support for promotion of health disparity research efforts,
2. Workgroup and protocol development engagement to ensure health disparities relevant data are
collected and that these data are used responsibly,
3. Consultative resources and programs to accelerate growth of the racial and ethnic diversity within the
consortium by expanding BIPOC scientists, trainees and staff, and enhancing the proportion of new
BIPOC hires over historical levels, and
4. Increase health disparities research training. The program will attract and increase training of BIPOC
scientists in the study of health disparities during adolescent development both within ABCD and,
ultimately, within the national developmental neuroscience workforce.

Public health relevance
PROJECT NARRATIVE This proposal is designed to enhance health disparities (HD) research in the ABCD consortium through leadership expansion, HD training, optimizing relevant data acquisition and use, and improved hiring practices. ABCD Coordinating Core will hire an Associate Director of Equity, Diversity and Inclusion with Health Disparities experience who will assist in the coordination of efforts already underway within ABCD, bring new training in health disparities research (design, conduct, analysis, and interpretation) to the ABCD community of scientists, and enhance the hiring of BIPOC staff and scientists to facilitate health disparities research application in neuroscience.